Kupambana: A Combined Microeconomic Strengthening and Stigma Reduction Intervention for Young People with HIV in Zambia

ABSTRACT
In low- and middle-income countries, young people with HIV (YPWH) experience the compounded effects of HIV
and poverty stigmas that jointly contribute to suboptimal mental health and HIV care continuum outcomes. Our
experience conducting research with YPWH in Zambia - which ranks among the ten countries with the highest
HIV prevalence worldwide - has revealed linkages between intersectional HIV and poverty stigmas and mental
health problems, which contribute onward to impact antiretroviral therapy (ART) initiation, retention in care, and
medication adherence problems among YPWH. In turn, attrition along the HIV care continuum drives high
mortality among YPWH.
Our formative work establishes the promise for microeconomic interventions with YPWH as a foundation to
improve well-being in this population of young adults experiencing the co-occurring challenges of HIV and
poverty. However, our formative work also highlights the need to address intersectional stigmas related to HIV
and poverty among young adults, in addition to providing livelihood intervention activities, as crucial components
to jointly improve the continuum of HIV care and mental health outcomes. In response to PAR-23-190, we
propose a combined intervention addressing intersectional HIV and poverty stigmas and strengthening economic
capabilities to improve HIV care continuum and mental health outcomes in YPWH in Zambia. This intervention
(tentatively named Kupambana or “to overcome”) includes an 8-week program involving two experimental
components: (i) stigma reduction support group, consisting of eight weekly group-based educational sessions
addressing self-care, health self-efficacy, resilience and empowerment, and coping strategies to minimize
internalized stigmas and (ii) vocational and entrepreneurship training (VET) voucher, worth 2,500 Zambian
kwacha [ZMW] (or ~150 USD), to pay for training fees and allow YPWH to obtain employable skills; and one
usual care component: (iii) a one-time financial literacy group-based educational session.
This application has two phases: adaptation and pilot test. Phase 1 will include interviews with ~25 YPLH and
15-20 key stakeholders and formation of a youth advisory board to inform the adaptation and implementation
process. Phase 2 will include evaluation of the feasibility, acceptability, implementation costs, and preliminary
effects of the Kupambana program on HIV care continuum, mental health outcomes, and mechanisms of change
such as stigma. We will randomly assign 100 YPWH to either experimental (Kupambana) or control (usual care)
group. We will conduct baseline, end-of-program, and two follow-up assessments at 3- and 6- months after end-
of-program. We will also conduct exit interviews to assess fidelity and implementation procedures. If this research
shows promise, we will use the findings to support a sufficiently powered R01 application to implement a type 1
hybrid effectiveness-implementation.

Public health relevance
PROJECT NARRATIVE In this R01 study, we will adapt, and pilot test the Kupambana intervention to address intersectional HIV and poverty stigmas and their impact on mental health, progression across the HIV continuum of care, and mechanisms of change, such as stigma, among young people with HIV in Zambia. The pilot test of Kupambana will evaluate its feasibility, acceptability, implementation costs, and preliminary effects. If findings show promise, this research will form the basis of a subsequent type 1 hybrid effectiveness-implementation investigation of Kupambana.